Molecular Pathology and Genomics Core

PROJECT SUMMARY
Core C provides access to specialized professional and technical pathology services and genomic services
that are essential to the success of the Program. It does so by carrying out 3 overarching aims that support all
three P01 Projects: 1) provide pathology expertise needed for classification of primary human PTCLs and PDX
and murine PTCL models; 2) perform standard and novel in situ tests for biomarkers relevant to understanding
PTCL pathophysiology and its response and resistance to novel therapies; and 3) perform targeted exome
sequencing of a large cohort of well-characterized human PTCLs. The Core delivers these services at two
performance sites, one in Boston led by Jon Aster, which will deliver services supporting Aims 1 and 2, and the
second in North Carolina led by Sandeep Dave, which will deliver services supporting Aims 1 and 3. Delivery
of Aim 1 services relies on the Core's co-leader, Dr. Jon Aster, who is a practicing academic
hematopathologist with >25 years of experience with human and murine hematopathology, and is
supplemented by additional expertise in Project 1 (John Chan) and access to the Hematologic Malignancies
Research Consortium, which includes >25 institutions and has accrued over 1800 cases of T cell lymphomas,
a majority with paired normal tissue. Aim 2 services will be provided in Boston include standard histology and
immunohistology services and innovative, multiparametric immunofluorescence staining platforms, the Perkin-
Elmer Vectra platform and CyCIF is an iterative imaging platform that allows for evaluation of >50 different
markers on single FFPE slides. Aim 3 services are delivered at the North Carolina performance site by
performing targeted exome sequencing on 410 genes that are frequently mutated in lymphoma, initially using
DNA prepared from a cohort of 1833 PTCLs and paired normal tissue controls.

Public health relevance
PROJECT NARRATIVE Core C supports all 3 projects of the P01 focused on peripheral T cell lymphoma by providing professional and technical hematopathology services, innovative multiplex immunostaining platforms and data analysis systems, and state-of-the-art targeted exome sequencing and genomic data analysis pipelines. It also provides access to the Hematologic Malignancies Research Consortium, an international working group of over 26 institutions that are contributing cases, including over 1800 cases of peripheral T-cell lymphomas that are available for genotyping through Core C.